Clinical and Translational Predoctoral training in Alzheimers Disease and Related Dementias

ABSTRACT
Alzheimer’s disease and related dementias (ADRD) remains a devastating neurodegenerative disorder
that slowly compromises normal cognition and behavior, leading to death. In 2022, the national cost of
caring for ADRD patients was estimated to be $321B with an additional $271B in unpaid costs incurred
due to caregiving by family and friends. Despite this staggering statistic, there exist few treatments and no
cures for ADRD. A major impediment in designing interventions and therapies is the involvement of
heterogenous genetic risk factors, lifestyle factors and co-morbidities. Unraveling such a multifarious
pathogenetic mechanism would require scientists to cross traditional boundaries between disciplines.
Towards this, we had designed an interdisciplinary research and professional training program for
predoctoral students from a basic research department (Neuroscience) and a clinical department (Clinical
Health Psychology) at the University of Florida (UF). Since its inception in 2018, we have graduated 8
students and we have disseminated didactic knowledge and scientific discourse to our T32 community and
beyond. Notably, of the 18 trainees in our program, 11 are female and 6 are from disadvantaged
backgrounds. In this past funded cycle, UF leadership delivered close to $1.1M in Institutional support they
originally promised in the application. To continue this ADRD training framework, we now seek renewal
of our ongoing T32 program, in the form of the Clinical & Translational T32 in ADRD (CaTT-ADRD)
program. In this renewal application, we seek continued support to sustain a cross-disciplinary, diversified
and translational training program designed for pre-doctoral students to foster their professional and
academic trajectory into successful translational scientists in ADRD. Our renewal application introduces
new mentors and training inclusive of the artificial intelligence initiative at UF. We have been fostering the
next generation of ADRD scholar-leaders within our preceptor cohort, with one of these preceptors joining
our leadership in this renewal application. As before, our institution demonstrates their clear support for
this T32 program by providing direct Institutional support as well as general shared resources support. The
overarching goal of this proposal will be to build upon the outstanding existing infrastructure of
neuroscience training and the vast expertise in ADRD and clinical aging research at UF. Overall, our aims
are to provide (1) cross-disciplinary mentorship in research concepts and methodology, scientific analysis
and interpretation; (2) opportunities to train and interact with faculty who are leading authorities in the field
of ADRD and aging; (3) support for diverse dissertation committees that include secondary mentors to
promote broad-based and comprehensive training; (4) personalized mentorship for professional
development including grant writing, research communication, and networking; and (5) impetus to establish
programs to ensure continuing recruitment and training of underserved students.

Public health relevance
Project Narrative Alzheimer’s disease and related dementias refer to a wide group of relentless neurodegenerative diseases, with as yet unknown etiologies. This renewal application seeks continued funding to train predoctoral students studying clinical and translational aspects of Alzheimer’s disease and related dementias. Trainees from diverse backgrounds will receive support to participate in didactic coursework, mentored research and professional development in preparation for a future career in clinical and translational research in Alzheimer’s disease and related dementias.